Mechanisms regulating the formation and repair of neuronal activity-induced DNA breaks and their effects on learning behavior

Project Summary
Experiences have a remarkable influence on animal behavior. At the molecular level, the initiation of new gene
transcription in neurons is crucial for the development of experience-driven adaptive behaviors. Moreover,
defects in neuronal activity-dependent transcription programs manifest in cognitive deficits and neurological
disorders. Understanding how neuronal activity-dependent transcription is orchestrated is therefore significant.
A surprising new finding in this regard is that various paradigms of neuronal activity, including exposure to
learning behaviors, induce the topoisomerase, topoisomerase IIb (Top2B), to generate DNA double strand
breaks (DSBs) at specific loci within the genome of neurons. These activity-induced DSBs are enriched within
the promoters of prominent early response genes (ERGs), such as Fos, Npas4, and Egr1, and DSBs facilitate
the rapid transcription of these ERGs. These observations describe an intriguing mechanism that governs
neuronal activity-dependent transcription. However, precisely how the formation and repair of activity-induced
DSBs is controlled, how DSBs stimulate rapid ERG induction, and how defective DSB repair affects activity-
dependent transcription and learning behaviors remain obscure. These topics will be the focus of this project.
Preliminary data for this project indicate that neuronal stimulation triggers rapid Top2B dephosphorylation and
modifies its DNA cleavage activity. Employing high-resolution imaging and biochemical methods, the proposed
experiments will unveil the activity-dependent signaling mechanisms that modulate Top2B to generate DSBs at
specific genomic loci. A defining feature of genome-wide activity-induced DSBs is that they form at sites co-
occupied by CTCF. Chromatin looping by CTCF creates topological barriers to gene enhancer-promoter
contacts, and in preliminary studies, knockdown of CTCF elevated ERG levels even in the absence of neuronal
stimulation. These results suggest that CTCF constrains ERG expression, and that activity-induced DSBs could
be a mechanism to rapidly override CTCF-enforced topological constraints at ERGs. To test this hypothesis,
chromosome conformation capture (3C) will be utilized to reveal chromatin interactions at sites of activity-induced
DSBs and clarify how DSBs affect these interactions. Additionally, the roles of CTCF in regulating promoter-
enhancer coupling at ERGs will be explored following CRISPR-based mutation of specific CTCF sites. Neuronal
activity-induced DSBs are repaired through nonhomologous end joining (NHEJ). To assess the role of DSB
repair in vivo, previously utilized ChIP-seq strategies were applied to map DSBs formed in response to
physiological learning behaviors in the mouse hippocampus. Using this information and by employing similar
methods in an NHEJ-deficient mouse model, the proposed experiments will identify genome-wide sites that are
vulnerable to DSB accrual in the hippocampus, and study how defective DSB repair affects activity-dependent
transcription. Finally, NHEJ-deficient mice will be subjected to appropriate behavioral tasks to test how the repair
of activity-induced DSBs impacts learning and memory.

Public health relevance
Project Narrative Molecular changes in the nervous system that allow learning and adaptation to new experiences are incompletely understood. We recently made the surprising discovery that when stimulated, neurons incur DNA double stand breaks (DSBs) at specific sites in the genome, and that these DSBs promote the expression of genes that play crucial roles in experience-driven synaptic changes, learning, and memory formation. By characterizing the roles of physiologically generated DSBs in learning behaviors, and by elucidating how the formation and repair of these DSBs is regulated in neurons, this project will enhance fundamental knowledge of how behavior is shaped through experiences, and how disruptions in genomic stability diminish cognitive performance and trigger neurological disease.